HIV and its impact on Long COVID prevalence and manifestations

PROJECT SUMMARY
The purpose of this NIH F30 application is to support the PI, Skye Opsteen, and her mentored research and
career development for the next three years. The proposed activities will strengthen her potential to become a
successful physician scientist. The major goal of this project is to develop her experimental immunology skills to
inform the biologic basis of post-COVID syndromes, particularly in people with HIV (PWH) given their increased
baseline immune activation. The primary objectives of the research proposal are to investigate if the monocyte
and T cell population shifts typical of chronic HIV infection are exacerbated during long COVID, and how the
immune features of long COVID in PWH compare to people without HIV. Chronic inflammation has been
implicated in long COVID development and is known to drive increased rates of comorbidities in PWH; therefore,
studying long COVID in PWH offers a unique opportunity to characterize long COVID phenotypes driven by
chronic inflammation. This project will investigate monocyte-mediated inflammation, specifically the role of
CD16+ monocytes and inflammatory cytokines IL-1 and TNF in recovery versus long COVID development in
PWH, and how these responses contribute to clinical symptoms such as fatigue (Aim 1). The project will also
determine the contribution of adaptive immune responses during long COVID in PWH (Aim 2). Our long-term
objective is to inform future long COVID studies of potential diagnostic markers and therapeutic targets for
patients with long COVID phenotypes driven by persistent inflammation.
The proposed training plan for the PI is sponsored by her primary PhD mentor, Dr. Nathan Erdmann, and co-
mentor, Dr. Paul Goepfert. Included in the training plan are experiences that will help her develop in three major
areas: 1) rigorous immunological research in HIV and SARS-CoV-2, which includes developing familiarity with
the existing literature, critically evaluating published studies, and training in principles of scientific integrity and
responsible conduct of research; 2) competence in bioinformatic techniques and biostatistical analysis; and 3)
career and professional development, including grant writing, manuscript review, clear communication through
presentation and manuscript preparation, and translation of research findings to clinical applications. After
completion, this training plan will provide the PI with the foundation necessary for a successful career as a
physician scientist. Her ultimate career goal is to one day lead a translational research laboratory that studies
human immune responses to emerging and reemerging pathogens in the setting of chronic immune
dysregulation to assist in the clinical prevention and treatment of various infectious diseases in at-risk
populations.

Public health relevance
PROJECT NARRATIVE There is increasing evidence that chronic inflammation is a driver of long COVID in a subset of individuals; however, studies have predominately focused on immunocompetent individuals despite increased risk in people with HIV (PWH) and other groups experiencing persistent inflammation. This study proposes to investigate the impact of monocyte-mediated inflammation and adaptive immune responses on long COVID development in PWH, with an emphasis on how monocyte populations, diminished T cell functionality and impaired antibody production may contribute to persistent symptoms post-COVID. This proposal will further our understanding of how monocyte-mediated inflammation and adaptive immune responses contribute to long COVID development in PWH and will inform future studies into long COVID phenotypes driven by persistent inflammation.